Developmental Core

Project Summary Developmental Core (DC)
The D-CFAR Developmental Core will establish a centralized mechanism to provide mentoring, training, and
supplemental funding to enlarge, strengthen, and diversify the cadre of HIV investigators in St. Louis, the
Missouri region and beyond. To achieve this vision, the Developmental Core (DC) led by Drs. Fred
Ssewamala, Patricia Cavazos and Richard Grucza, will design and deliver critical resources through
leveraging our existing strengths and filling critical gaps. In Aim 1, we will create a structured mentoring
program that focuses systematic and personalized attention on emerging HIV investigators. We will prioritize
tailoring existing developmental resources in our environment, many funded via the Clinical Translational
Sciences Award (to WU and partner institutions including SLU). We will tailor these existing resources to the
needs of HIV investigators. We will also create new and targeted activities to fill gaps (e.g., consultation for
HIV researchers). We will guide utilization by creating a community of emerging investigators through a HIV
works-in-progress (H-IP) group that will provide structured expertise as well as peer-to-peer learning. Overall,
we will create a system that reflects contemporary “sociological” views on mentoring, which see a trainee in
relation to an ecosystem of resources in which one or more mentors play important, but not exclusive roles, in
growth. In Aim 2, we will strengthen the quality and culture of mentorship related to HIV research. We will
establish a three-component “mentor-the-mentor” training program including a Leadership Development in HIV
Workshop, mentorship attendance at the annual inter-CFAR meeting, and a “Mentoring Symposium in HIV”
seminar that will include an invited speaker and awards for mentoring as well as mentored research. In Aim 3,
we will provide supplemental support and funding to facilitate growth of emerging HIV investigators conducting
interdisciplinary research. Supplemental funding will support translational and transdisciplinary development of
investigators, help span traditional environmental silos both within academia and between academia and
regional community public health stakeholders. Together these activities will form a critical pillar of the D-
CFAR, and enlarge our network, advance scientific response to HIV, and turn the tide on the epidemic in St.
Louis, greater Missouri and beyond.